Evaluation of Potential Enteric Vaccines to Induce Reactive Arthritis

This IAA supports in vitro studies examining the effects of Shigella, Salmonella, BCG and control bacterial strains on the effector functions of human immune system cells.